GROWTH FAILURE DUE TO LACK OF ADEQUATE ENDOGENOUS GROWTH HORMONE PRODUCTION

This study assesses the growth response of subjects with growth failure due to inadequate growth hormone production established by integrated growth hormone concentration. Growth hormone levels are integrated over a 24-hour period in children who demonstrate normal growth hormone response to provocative stimuli. Growth response following administration of recombinant growth hormone is evaluated after one year of therapy.